Influence of language input quantity, dyadic quality of interactions, and word learning skills on typical and atypical patterns of early dual language development

Project Summary
Language ability before entry to kindergarten is among the best predictors of later success in school, yet the
evidence base to support oral language development in Dual Language Learners (DLLs) across the full range
of language abilities is lacking. To address this known gap, this research investigates the specific contributions
of (a) the quantity of language input in the home environment, (b) the quality of language learning opportunities
during interactions with caregivers, and (c) language learning processes that support children's bilingual
language development. The central hypothesis is that a multidimensional approach to bilingual development
that includes child, dyadic, and family factors will more strongly predict learning outcomes. Critically, this work
will include children across the full continuum of language development – from typical skills in both English and
Spanish to children with weak skills in both languages (i.e., language delayed). Under Aim 1, we test toddlers'
ability to make rapid inferences about the meaning of a novel word based on limited exposure (i.e., fast-
mapping) in English and Spanish, asking how word learning relates to vocabulary and grammatical
development in children with varying levels of language skill. Under Aim 2, we examine how the quantity of
dual language input and the quality of language learning opportunities during caregiver-child interactions
explain variability in word learning performance and subsequent bilingual language outcomes one year later.
To meet these aims, DLLs and their caregivers will be studied longitudinally across a well-known period of
rapid lexical acquisition in toddlerhood. This work is significant because it will identify the contribution of child,
dyadic, and family variables for bilingual language development and examines these factors across the full
continuum of language skills. The proposed work is innovative because it (a) tests bilingual word learning skills
by evaluating fast-mapping in both English and Spanish; and (b) takes an interdisciplinary and
multidimensional approach to language development including the child's language learning skills in
combination with the learning environment. Data will provide new insight into sources of variability that
influence early dual language trajectories, and point to strategies for supporting long-term language success.

Public health relevance
Project Narrative This research investigates how the quality and quantity of dual language input relates to word learning in toddlers along a continuum of language abilities including those with typically developing skills in Spanish and English to those diagnosed with early delays in both Spanish and English. Findings have the potential to greatly advance theoretical understanding of the complex interdependencies between the bilingual child's linguistic environment and language learning processes. Data from this project include complementary longitudinal measures that may support future research aimed at tailoring preventive and therapeutic interventions to the child's unique developmental profile and environmental supports in not one language, but two.